Integrating cell identities and morphodynamics through extracellular cues

PROPOSAL SUMMARY/ABSTRACT
Establishing proper cell identities and tissue architecture during early embryogenesis is crucial for a
successful pregnancy. Coordination of these processes is integral to patterning the mammalian embryos as they
increase complexity from the implantation stages. However, how this tight coordination is regulated remains
poorly understood. A high rate of mortality seen in human embryos during the first 2-3 weeks post-fertilization is
a major cause of early pregnancy loss, yet the essential cellular, molecular, and mechanical changes remain
almost entirely uncharacterized.
Rather than merely a structural component that provides physical support, recent studies have shown that
the extracellular matrix (ECM) has emerging roles in regulating cell fate specification and morphogenesis. My
recent work reveals that the embryonic basement membrane (BM), a specialized ECM, plays an essential role
in patterning the early post-implantation mammalian embryo. My preliminary results lay the foundation of my
proposal to determine how the BM coordinates the collective cell behaviors and facilitates pattern formation at
critical developmental stages of early mammalian embryogenesis.
We will apply novel technologies, including 4D quantitative imaging and single-cell spatial genomics,
combined with in vivo, in vitro, and in silico approaches to test the hypothesis that the BM facilitates embryo
patterning through coordinating cell fate specification and tissue morphodynamics. In my first aim, we will
comprehensively map the cell behaviors and the morphodynamics of the developing embryos with 3D
quantitative imaging and timelapse imaging approaches. We will define the role of the BM through genetic
manipulations in stem cell-derived embryo-like models as well as in the natural embryos. In my second aim, we
will map the BM organization and apply single-cell spatial transcriptomics approaches to generate in situ fate
maps. We will functionally test how the BM regulates cell identities by quantitatively defining gene expression
patterns with BM architecture and validate the findings with loss-of-function analyses. Next, we will build
mathematical models that integrate cell identities and cell dynamics with the BM mechanics to uncover
mechanisms of pattern formation. In my third aim, we will apply the technologies and tools developed in the
previous two aims to explore the roles of the BM in shaping the formation of germ layers during gastrulation.
Overall, my proposed work will increase our understanding of how extracellular cues facilitate a successful
pregnancy and could inspire novel therapeutic approaches to prevent early pregnancy loss. The training provided
by this award will allow me to acquire the necessary skills to develop my independent research program to apply
a quantitative systems-level approach to uncover the dynamics, functions, and regulations that shape the
embryos at critical stages of early pregnancy.

Public health relevance
Project Narrative How cells acquire their identities must be tightly coordinated with how tissues develop to their proper shapes in early mammalian embryos as they increase complexity from the implantation stages. Defects in this coordination often leads to embryonic lethality, which is one of the major causes of early pregnancy loss. My proposed work will reveal how the extracellular cues coordinate these processes required for early embryonic patterning and could inspire novel therapeutics to prevent early pregnancy loss.